Correcting Aberrant Splicing of the Human CD22 Gene

DESCRIPTION (provided by applicant): B-precursor acute lymphoblastic leukemia (BPL) is the most common form of cancer in children and adolescents. This project addresses an urgent and unmet need for the treatment of aggressive, treatment refractory BPL. Two recent studies have found a deletion of CD22 exon 12 (CD22ΔE12) in primary leukemic cells in the vast majority of pediatric patients with poor prognosis, newly diagnosed, or relapsed BPL. RT-PCR analysis of primary leukemic cells in matched pair diagnosis vs. induction failure specimens, and diagnosis vs. 1st bone marrow relapse specimens provided direct evidence that the CD22ΔE12 genetic defect is detectable at the time of initial diagnosis in therapy-refractory pediatric ALL patients. Preliminary studies support the hypothesis that correction of CD22ΔE12 results in the loss of self-renewal capacity and significantly reduces the clonogenicity of leukemic cells. We intend to develop the therapeutic potential of an RNA technology that corrects expression of the mutant form of CD22 to generate a potent anti-leukemic activity. Functional testing will be performed in patient-derived BPL cells in vitro and in vivo, using a mouse/human xenograft model to identify 1-3 pre-clinical candidates. Successful completion of this project may lead to the development of a new, paradigm- shifting therapeutic innovation for BPL as well as other cancers associated with deletions in CD22.

Public health relevance
PUBLIC HEALTH RELEVANCE: B-precursor acute lymphoblastic leukemia (BPL) is the most common form of cancer in children and adolescents. This project addresses an urgent and unmet need to develop a new treatment option for aggressive, treatment refractory BPL by correcting a mutation in a growth inhibitory signaling gene called CD22, which is highly associated with poor prognosis.